Research Symposium in Communication Sciences and Disorders

? DESCRIPTION (provided by applicant): This application proposes continued support for the Research Symposium in Communication Sciences and Disorders at the annual Convention of the American Speech-Language-Hearing Association and the Research Symposium Travel Award. The Travel Award will provide funds to support the participation of 75 early-career scientists in communication sciences and disorders and related disciplines. Through a full day conference and mentoring opportunities that occur before, during, and after each Symposium, the Research Symposium, now in its twenty-fifth year, will be effective in helping promising, early-stage scientists to become integrated into their scientific community and to help them succeed in becoming productive scholars. The scientific base of the discipline will be strengthened through the publication of Symposium articles in a Research Symposium Forum submitted each year to the Journal of Speech, Language, and Hearing Research. The Travel Award mechanism provides an opportunity for protégés to work with their mentors to complete a mentored review of one of the articles submitted by the Symposium speakers. Protégés will work with their mentors in advance to prepare questions for the question-and-answer period following each presentation based on their reading of the articles identified by each speaker. During the Symposium, protégés will be invited to ask questions of the speakers. Both the presentations and the question-and-answer periods will be recorded (audio synced with slides) and these videos will be captioned and made freely accessible through the ASHA Research Symposium website. The Research Symposium grant aims to advance the research career development of approximately 75 early-career scientists focused on research in communication sciences and disorders over the next 5 year funding cycle and to advance scientific dialog and widespread dissemination of recent research on five clinical areas of central importance to the communication sciences and disorders discipline.

Public health relevance
PUBLIC HEALTH RELEVANCE: The American Speech-Language-Hearing Association Research Symposium conference grant aims to advance the communication sciences and disorders knowledgebase to improve the communication development and health of humans. The associated Travel Award program seeks to strengthen the research workforce of scientists addressing communication sciences and disorders. The Travel Award will provide funds to support attendance at the Research Symposium and mentoring support to 75 early-career scientists before, during, and after the Research Symposium. Dissemination of the Symposia presentations will include peer-reviewed publications and captioned recordings, both of which will be made freely available. Through this five-year initiative, the quantity and quality of research addressing communication health will be substantially increased; thereby, improving outcomes for those with communication disorders.